Immune and transcriptomic biomarkers of progressive oral premalignant lesions

PROJECT SUMMARY
Oral squamous cell carcinoma (OSCC) is the 6th leading cause of cancer-related mortality worldwide. OSCC is
curable with favorable survival outcomes if detected early. The majority of OSCCs are preceded by oral
potentially malignant disorders (OPMDs) with oral leukoplakia or white lesions being the most common type.
However, not all oral leukoplakia progresses to OSCC. Accurate identification of OPMDs that are likely to
progress to OSCC offers the best strategy for OSCC prevention and management and can lead to decreasing
patients’ morbidity and mortality through earlier detection. Although proven inadequate, microscopic examination
and histological grading remain the gold standard for predication of malignant transformation. For instance, some
low-grade OPMDs will progress to OSCC but not all high-grade OPMDs progress to OSCC. There is an urgent
and unmet demand for highly efficacious biomarkers to identify progressive leukoplakias with a high risk of OSCC
conversion. Addressing this knowledge gap can lead to early detection of HPV-negative OSCC and improve
patient survival. Examining OPMDs with and without malignant transformation, we have found specific
transcriptomic signatures which are associated with progressive OPMDs. Using spatial transcriptomics and
multiplex immune fluorescence (mIF), we observed that malignantly transformed OPMDs have significantly
increased immunosuppressive tumor-associated macrophages (enriched in ARG1) and low levels of CD8+ T-
cells. Our central hypothesis is that the levels and trajectories of such signatures in tissues are predictive of the
malignant conversion of OPMDs to OSCC. The primary objective of this multi-disciplinary U01 collaborative
study is to identify and validate transcriptomic and immune signatures that can discriminate OPMDs predicted
to malignantly progress and develop, validate, and refine a risk stratification model based on identified
biomarkers and clinical variables. In Aims 1 and 2, we will leverage a well-characterized, racially diverse
population of over 500 individuals with histologically confirmed OPMDs. We will validate our list of transcriptomic
and immune-related biomarkers and perform RNA sequencing and spatial transcriptomics to identify potential
additional transcripts associated with the malignant progression of OPMDs. In Aim 3, we will develop a
combination risk score formula based on selected transcriptomics and immune biomarkers and
clinicodemographic variables to predict OMPD malignant progression based on our internal cohort. We will
validate the combination risk score formula in an independent cohort of 300 patients. The risk score formula can
be used by clinicians for risk assessment and clinical decision making. The contribution from this project is
expected to be significant as it can lead to introduction of a personalized risk stratification approach for
management of OPMDs. Detecting preneoplastic lesions with high malignant transformation risk will substantially
increase patient survival while maximizing OSCC screening benefits.

Public health relevance
Protect Narrative The overall survival rate of oral cancer has only marginally improved in the last few decades due to its late diagnosis. This project aims to use a combination of gene expression, immune cell profiling, and clinical information to identify biomarkers to predict the development of oral cancer from pre-malignant oral lesions. By identifying these markers, it is possible to more accurately predict which premalignant lesions are at risk of progressing to cancer to provide guidance to clinicians for appropriate management with a concomitant reduction in oral cancer morbidity and mortality.